Improvement of genetic analysis in the pathogenic zygomycete Mucor circinelloides

? DESCRIPTION (provided by applicant): This proposal aims to develop enhanced genetic analysis systems in the zygomycete fungus Mucor circinelloides. M. circinelloides is an opportunistic fungal pathogen that causes mucormycosis. The incidence of mucormycosis is increasing due to a rising number of immunocompromised individuals. M. circinelloides also serves as a model system to study light sensing and understand RNAi-mediated gene expression regulation. In addition, M. circinelloides is a candidate for biofuel production. However, the genetic analysis of this fungal system is limited due to 1) a limited number of markers for transformation and 2) inefficient transformation and low frequent homologous gene replacement. In the studies proposed within this document, we aim to enhance our ability for genetic analysis in this important fungal system by proposing three aims: 1) construction of a recyclable pyrG marker system and 2) enhancement of homologous recombination in gene disruptions.

Public health relevance
PUBLIC HEALTH RELEVANCE: We propose to develop robust genetics systems in Mucor circinelloides, one of the causal agents of mucormycosis, which is recognized as an emerging fungal infectious disease. Infection most frequently involves patients with diabetes, AIDS, hematologic malignancies, hematopoietic stem cell/solid organ transplantation, or trauma. Zygomycetes within the order Mucorales are causal agents of mucormycosis. However, genetics and molecular biology in zygomycetes are less well developed compared with model and even other pathogenic fungi. Our proposed work will shed light and provide a novel forum in the molecular biology and genetics of the understudied pathogenic zygomycetes.